Radiogenomic predictors of treatment response in head and neck squamous cell carcinoma

Despite recent advances in treatment of head and neck squamous cell carcinoma (HNSCC), five-year
overall survival (OS) has remained poor due to high rates of disease progression after treatment. A lack of
reliable prognostic biomarkers limits ability to predict disease progression in non-human papillomavirus
(HPV) mediated HNSCC. Among candidates for salvage surgery in the setting of disease progression after
primary chemoradiotherapy, 5-year OS is estimated at just 16%. Radiomics, involving analysis of large
numbers of quantitative tumor imaging features, has been used to develop image-based prognostic
models. Delta radiomics incorporates differences between pre- and post-treatment images, thereby
capturing quantitative measures of treatment response. To address critical need for prognostic biomarkers
for patients with HNSCC, we aim to develop and validate radiogenomic models to predict 2-year overall
and progression-free survival using tumor-derived genomic biomarkers and delta radiomic features derived
from pre- and post-treatment contrast-enhanced computed tomography. Prior studies developed highly
accurate models of cancer treatment response using delta radiomics, but not in patients with locoregionally
advanced HNSCC. Few studies have evaluated reliable and concordant genomic and radiomic prognostic
phenotypes in HNSCC. We hypothesize that a multi-‘omic model integrating radiogenomic features will
accurately predict 2-year overall and progression-free survival. We aim to 1) develop a fully annotated,
patient-centered, clinical outcome and radiographic dataset with associated tumor samples for patients with
locoregionally advanced HPV-negative HNSCC treated with definitive chemoradiotherapy and 2) develop
radiogenomic models to predict 2-year OS and PFS using tumor-derived genomic biomarkers and delta
radiomic features derived from pre- and post-treatment contrast-enhanced computed tomography. We will
engage the Quantitative ‘Omics Core to extract radiomic features and explore radiogenomic phenotypes
associated with 2-year OS and PFS. We will use the Biobanking and Biomarker Validation core to generate
a HNSCC patient-derived tissue microarray to identify mutations and quantify gene expression relevant to
epidermal growth factor receptor, MAPK-associated protein kinase 2 (MK2) and hypoxia pathways. With
the Patient and Community Engagement core, we will ensure that patient priorities are consistently
represented in the design. Long-term goal is to support future trials aimed at early identification of patients
at high-risk of disease progression who are likely to benefit from precision treatment approaches.